Single molecule dissection of Arp2/3 complex activity and regulators in living cells

Project summary
Actin assembly by the Arp2/3 complex is an essential component of a large and expanding list of cellular
processes that are necessary for life. Therefore, it is not surprising that Arp2/3 complex dynamics are regulated
by a complex collection of binding partners that provide core homeostatic functions. The elaborate nature of
Arp2/3 complex regulation enables cells to adapt to diverse environmental cues that play key roles in physiology
and diseases. Accordingly, dysregulation of Arp2/3-actin assembly disrupts the mechanobiology of tissues while
also providing mechanisms for cancer cells to become metastatic. A critical gap lies in the fact that, in most
cases, the mechanistic chain of events leading from the deployment of specific biochemical activities to the
effects on cellular physiology remain unestablished. Closing this gap requires resolving the discrete cellular
spatiotemporal nanodomains in which a protein's distinct biochemical functions are active. Recent advances in
live-cell single molecule tracking (SMT), super-resolution microcopy, quantitative analytical pipelines, and
CRISPR-Cas9 gene editing have made it possible to pinpoint the kinetics of protein-protein interactions in their
native cellular contexts. The principal investigator has demonstrated expertise in these technologies while
uncovering principles of cytoskeletal self-organization and cellular mechanisms of Arp2/3 complex-driven
lamellipodial protrusion and cell migration. Therefore, taking advantage of this toolbox of cutting-edge
technologies to identify nanodomains of protein activity in mammalian cells, we will combine cellular and genetic
methods with SMT to unravel three core themes of Arp2/3-actin network regulation: (A) when, where and how
mammalian cells employ the recently discovered noncanonical unbranched Arp2/3-actin assembly pathway, (B)
the concurrent cellular mechanisms of Arp2/3-actin junction stabilization and signaling feedback that have
previously been unresolvable, and (C) how Arp2/3 networks are locally controlled by competing activating and
inhibitory mechanisms. The resulting findings will offer deep molecular insights into diseases associated with
disrupted Arp2/3 complex pathways (metastatic cancer, neurological and immune dysfunctions). These
discoveries will advance our long-term goal to build a framework describing the integrated landscape of
biochemistry controlling Arp2/3-driven cellular processes.

Public health relevance
Project narrative Arp2/3 complex-based actin assembly is at the heart of cellular mechanics, motility and tissue homeostasis, and is dysregulated in cancer and many other diseases (autism, depression, colitis and more). The integrated mechanisms connecting the biochemistry and cell biology of Arp2/3-actin network driven processes are undefined in most cases, making it difficult to chart effective therapeutic action. This program innovates a solution to this gap in knowledge with an approach to precisely locate key biochemical activities in time and space within living cells using the latest microscopic and genetic advances.